Statistical Methods for Cancer Detection Using Biomarkers

PROJECT SUMMARY/ABSTRACT
In cancer research, precision medicine hinges on the development of valid biomarkers for cancer diagnosis, dis-
ease prognosis, and prediction of response to speciﬁc therapeutic interventions. Fueled by the rapid recent ad-
vances in the scientiﬁc knowledge of molecular biology and high-throughput omics technologies, a large num-
ber of candidate biomarkers for various cancers have been or are being identiﬁed. Statistical and computational
methods play a critical role in rigorously evaluating these biomarkers and further developing clinically relevant
prediction rules to ultimately improve and advance cancer treatment and patient management. However, most
existing methods, for continuous biomarkers, target diagnostic accuracy measures dictated by mathematical con-
venience rather than clinical utility. Particularly, a screening or diagnostic test in many clinical contexts needs to
maintain a high sensitivity (or speciﬁcity) and thus speciﬁcity at a controlled sensitivity level (or sensitivity at a
controlled speciﬁcity level) is a clinically desirable accuracy metric. Yet, statistical and computation methods for
this metric are mostly lacking, or suboptimal even when available as in limited circumstances. To address this ur-
gent analytic need, this proposed project will develop novel and efﬁcient statistical and computational methods
speciﬁcally targeting this accuracy metric of clinical interest. When a single biomarker is under consideration or
compared with another biomarker, Aims 1 and 2 will provide statistical tools for the inference and for covariate
adjustment. On the other hand, multiplex prediction rules that prudently combine multiple biomarkers hold the
promise to achieve improved diagnostic accuracy, since many cancers are heterogeneous. For optimal multiplex
rule formulation, Aims 3 and 4 will develop computation algorithms and statistical inference methods with both
linear combination and, often biologically and clinically motivated, logic combinations. These proposed ana-
lytic methods will be thoroughly investigated through rigorous asymptotic studies and extensive simulations.
They will be applied to a number of our prostate cancer biomarker studies, which motivated this project, from
the Early Disease Research Network (EDRN). User-friendly computer software will be made available to the re-
search community. These proposed methods will facilitate more effective biomarker research for cancer as well
as other diseases.

Public health relevance
PROJECT NARRATIVE The proposed project develops novel and efﬁcient statistical and computational methods for disease detection using biomarkers. They will facilitate biomarker evaluation and further formulation of multiplex prediction rules to guide treatment and patient care for cancer and other diseases.